Elucidating the Role of Microenvironment Mechanics in Regulating Cardiac Myofibroblast Plasticity

PROJECT SUMMARY
Fibrosis underlies a vast number of cardiac pathological conditions, ranging from genetic cardiomyopathies to
ischemic heart failure. Although substantial progress has been made in identifying molecular signals that trigger
the characteristic activation of quiescent cardiac fibroblasts (CFs) and their transdifferentiation into
myofibroblasts (MyoFBs), far less is known about the mechanisms that govern their long-term fate and
persistence, which presents major obstacles to the development of effective anti-fibrotic therapies.
This K99/R00 application describes a five-year research training plan that proposes to leverage (i) human
induced pluripotent stem cell-derived cardiac fibroblasts (iPSC-CFs), (ii) engineered biomaterials with tunable
mechanical properties, and (ii) single-cell multiomics platforms to investigate molecular mechanisms that govern
MyoFB fate and plasticity. Given the well-established sensitivity of CFs and MyoFBs to extracellular matrix (ECM)
stiffness, the applicant Dr. Sangkyun Cho will test the hypothesis that modulation of ECM-mediated mechanical
signaling potentiates the de-differentiation of MyoFBs, by synergizing with soluble factors known to regulate
major pathways in fibrogenesis. In Aim 1 (K99), Dr. Cho will use reporter iPSC lines (with fluorescently tagged
canonical MyoFB ‘marker’ genes, e.g., CFP-TAGLN) and a novel dynamically softening hydrogel system to
characterize in real-time the effects of mechanical unloading on MyoFB fate. In Aim 2 (K99), Dr. Cho will
investigate the synergy between ECM softening and the TGF-beta pathway in regulating MyoFB states, (i) by
examining stiffness-dependent protein interactions among mechanosensitive transcription factors (e.g., yes-
associated protein 1 (YAP)), and (ii) by identifying epigenetic regulators downstream of ECM stiffness with single-
cell assay for transposase transposase-accessible chromatin (scATAC-seq). In Aim 3 (R00), Dr. Cho will identify
potential druggable targets along the cell’s mechanosensory apparatus, and test candidate compounds in
engineered heart tissues and a mouse model of pressure-overload induced hypertrophy and heart failure.
The proposed studies build upon PI Dr. Sangkyun Cho’s well-suited prior training in biomaterials, proteomics,
and ECM mechanobiology, while providing new training opportunities in (i) reporter iPSC-CFs, (ii) single-cell
multiomics platforms, and (iii) animal models. Mentor Dr. Joseph Wu is a pioneer in iPSCs and cardiovascular
biology, and co-mentor Dr. Sarah Heilshorn is a leading expert in biomaterials and regenerative medicine,
whose mentorship complements that of Dr. Wu. Advisory Committee members Drs. Jeffery Molkentin (cardiac
fibrosis), Joseph Hill (heart failure models), and Michal Snyder (single-cell genomics) provide additional expertise
and guidance. In Summary, the well-tailored research training plan, exceptional mentoring team, and an
outstanding Environment at Stanford University are anticipated to help propel Dr. Cho toward his long-term goal
of establishing an independent research program at the intersection of bioengineering and cardiovascular
stromal biology.

Public health relevance
PROJECT NARRATIVE Cardiac fibrosis is a major cause of morbidity and mortality worldwide, affecting almost all forms of cardiovascular disease, but no effective therapies are currently available. This study will investigate the molecular mechanisms that regulate the long-term fate and persistence of myofibroblasts, the key driver and mediator of fibrosis. The proposed studies will likely provide new fundamental insights into cardiac stromal biology, and open potential avenues for the development of novel therapeutic strategies against fibrosis.